INHERITANCE OF CALCIUM ABSORPTION AND ITS RELATIONSHIP TO BONE DENSITY

Calcium absorption in adult mono and dizygotic twins will be examined from inheritance from the comparison of the variance of absorption in the 2 populations. The same will be done on measurements of plasma calcitriol, calcidiol, vitamin D binding protein, PTH and calcitonin and plasma and urine calcium and phosphate.